Genomics Summer Research for Minorities: A Pathway to Promote Diversity in Science Research

PROJECT SUMMARY / ABSTRACT
Historically, minorities have been underrepresented in STEM (Science, Technology, Engineering and Math)
related fields. Underrepresented minorities make up 32.7% of the total population of the United States, but only
account for 13% of the total number of employees in science or engineering fields. Recognizing the need to
promote diversity in the STEM workforce, we propose to develop an internship program that provides minority
students with a pathway to gain the necessary skills and experience to attend graduate school. Our proposal
will collaborate with the outstanding Genomics resources at the University of Utah and the existing, exceptional
undergraduate research internship programs already on campus. The overall goals of this program are to
provide minority undergraduate participants with quality research opportunities in genomics fields. This
includes training in bioinformatics and analysis of genomic datasets, and overall professional development. We
aim to provide participants with skills and a pathway to successfully navigate graduate school. Undergraduate
participant outcomes will be tracked and long-term support services will be provided to ensure future success
of all participants. Through this proposal, we aim to increase the pipeline of minority students into bioscience
and genomics research careers.

Public health relevance
PROJECT NARRATIVE The Genomics Summer Research for Minorities Program is designed to increase diversity of the science workforce within the United States by seeking to develop a holistic internship serving minority students interested in conducting research on the human genome. Our participants will work with researchers at the University of Utah gaining valuable skills in genome research. To accomplish this our program proposes to support the scientific development of each undergraduate participant, but additionally we aim to provide them with skills in writing, interviewing and development of a scientific network to support their successful navigation to and through graduate school.